ANTIRETROVIRALS AND SPREAD OF HIV DRUG RESISTANCE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. These folks are at the Cleveland Clinic Foundation, and we are collaborators with them on a study of drug treatment and prevention strategies for AIDS in S. Africa. I am partially funded through their Gates award. We would like to use the filesystem on axon as a transfer location for large files. Later on in the year I will be running simulations for them on axon.